Nursing homes' visitation bans during the COVID-19 pandemic: Effectiveness and consequences.

PROJECT SUMMARY/ABSTRACT
As of May 2022, there have been over 1 million COVID-19 cases and over 150,000 COVID-19 deaths among
U.S. nursing home residents. One of the most widespread mitigation measures implemented by nursing homes
was a visitation ban. In March and April 2020, 31 states issued state-wide visitation bans, affecting at least 66%
of facilities and 70% of residents in the U.S. Visitation bans may prevent transmission between facilities and the
community. Yet, any ban is incomplete because of staff who travel between the facility and the community. To
our knowledge, there is no empirical study examining the effectiveness of visitation bans on preventing COVID-
19 infection rates, hospitalizations, and deaths. What also matters are the adverse effects of visitation bans on
residents. Visitation bans can substantially reduce informal care, increase social isolation, and disrupt routine
care, resulting in adverse events such as decreased function and increases in depression, falls, and
hospitalization. Residents with Alzheimer's Disease & Related Dementias (ADRD), who rely more on caregivers,
may have a greater risk of adverse events than those without ADRD. Our team has collected visitation data at
both the state and facility levels, which document the dates when states initiated and lifted bans, as well as
weekly bans data at the facility level in Ohio. We also collect open-ended comments from family members from
a state-wide family satisfaction survey in Ohio. By linking data on visitation bans with national Medicare claims
and assessment data, we propose a convergent parallel mixed methods study to examine the
effectiveness and adverse consequences of visitation bans in nursing homes. We will study the 9,876
nursing homes in the 31 states that banned indoor visitation in March 2020, then lifted those bans between June
and November 2020. We will also study the 701 nursing homes in Ohio, where we have weekly data on the
presence of bans for each facility. Matched case-control design on prior infection rates and Hierarchical
Generalized Linear Mixed Models will examine the association of lifting visitation bans with COVID-19 and health
outcomes. Focus group interviews with direct care staff and analyses of family comments will be conducted to
examine the effects of visitation bans on daily care practices and resident health outcomes. Understanding both
the benefits and harms of visitation bans can inform future pandemic responses in nursing homes.
The specific aims of this project are: 1) To assess the effectiveness of visitation bans on preventing COVID-19
infection (primary), hospitalization, and deaths among nursing home residents; 2) To evaluate the association of
visitation bans with changes in function (primary), mood/behaviors, and adverse events among long-stay
residents with or without ADRD; and 3) To understand how visitation bans affected daily care practices within
nursing homes and resident health outcomes.

Public health relevance
PROJECT NARRATIVE Visitation bans in nursing homes were a major policy intervention in response to the COVID-19 pandemic, yet there is limited knowledge regarding their effectiveness in COVID-19 prevention or the unintended adverse effects on residents and care practices in nursing homes. By analyzing unique visitation ban data at the state and facility level, this study will provide timely information on both the positive and negative effects of visitation bans, with a special focus on residents with Alzheimer's Disease & Related Dementias, which will help policymakers better understand the full impact of this controversial mitigation measure. This is especially policy- relevant currently, because many states have passed or are considering passing laws to ensure visitation rights among nursing home residents, even during a pandemic.